Enhancing the Effectiveness of Community Health Workers to Reduce Cervical Cancer Disparities in African American Women

PROJECT SUMMARY/ABSTRACT
The hysterectomy-corrected incidence of cervical cancer (CC) is more than 40% higher among African
American women than white women. Black women are also twice as likely to die from CC. It does not have to
be this way. Widespread screening and proper follow-up would eliminate most new cases of CC because the
natural progression of precancerous cervical lesions is slow, allowing for treatment and cure. The best evidence
indicates that this is not happening. Adherence to screening guidelines is too low among Black women.
One promising solution to this problem is patient navigation (PN). PN was originally developed to help
socioeconomically disadvantaged Black women overcome the systemic, provider, and personal barriers to
timely cancer prevention and care using community members as lay navigators. Recently, however, there has
been a general shift away from navigating poor and uninsured patients, towards higher SES patients in better
funded, more comprehensive cancer care centers. While nearly all can benefit from PN, if not targeted to those
most in need, delivering these services to more privileged patients can exacerbate disparities.
In previous pilot work, we developed and tested a prototype, mobile PN intervention for both African
American women (mNav) and lay navigators (mNav-D) to reduce CC health disparities. These products are
front-ends to the same server-based program, and thus fully integrated. For patients, mNav includes an
integrated web-based risk assessment that allows our SMS software app to select and deliver videos and text
messages specific to each woman’s particular cervical screening challenges. Pilot work with 42 African
American women ages 21 to 65 informed the development of this product. For lay navigators, mNav-D
provides an “at a glance” overview of key performance metrics while also supporting easy entry of encounter-
level patient data. Development of this product was informed by formative research with 16 PNs working in a
range of settings. We also interviewed 12 participants who either had upstream or downstream touch points
with electronic health record (EHR) workflows. The data across these pilot studies strongly supports the
feasibility and potential effectiveness of these products, far exceeding the proposed benchmarks.
During Phase II we will complete development of mNav and mNav-D in consultation with our three
content experts. We will then examine the effectiveness of mNav and mNav-D to increase adherence to cervical
screening guidelines via medical review among nonadherent African American women. Participants will be
randomly assigned to either the intervention condition (PN + mNav/mNav-D) or to usual care (PN only).
Secondary measures will assess cancer screening knowledge, benefits and barriers of cancer screening, and
intentions.

Public health relevance
PROJECT NARRATIVE The goal of this project is to develop a patient-facing cervical cancer behavioral intervention (mNav) to help African American women identify and overcome barriers to cervical cancer care by providing health education and promoting self-efficacy, health literacy, and communication with healthcare providers. mNav-D, an integrated dashboard, will help lay navigators focus on issues they are best suited to handle (e.g., problems with insurance or transportation). The ultimate goal of this suite of products is to eliminate cervical cancer disparities among African American women.